Comprehensive Anesthesia Research Training

PROJECT SUMMARY
The broad goal of our T32 training grant program is to provide in-depth research training to talented individuals
who are committed to pursuing basic, translational and/or clinical research on topics in anesthesiology, critical
care medicine, pain medicine and the perioperative sciences. Our program structure ensures that trainees
learn state-of-the-art research techniques, the fundamentals of posing research questions, the critical thinking
involved in analyzing and reporting their results, and the tools and skills required to perform research rigorously
and ethically. Through direct mentored research, formalized didactic training, seminars and conferences, our
trainees learn to design and conduct laboratory experiments and clinical studies, to formulate and write grants,
to perform appropriate statistical analyses, and to understand the regulations, reproducibility and ethical issues
that are involved in research. Our program optimizes functional interactions between trainees and diverse
faculty mentors, and it provides an environment in which trainees can develop into high quality clinically
relevant researchers with the skills to effectively collaborate with both clinical and basic science investigators.
Faculty are organized into 5 tracks that encompass the broad areas of research focus in the Department of
Anesthesia: (1) Critical Care and Immunology, (2) Neurosciences and Pain, (3) Omics, Bioinformatics, and
Medical Informatics, (4) Outcomes and Disparities Research, and Implementation Sciences, and (5) Molecular
Biology and Biomedical Imaging. Each track is overseen by an appropriate senior faculty researcher and
includes physician-scientist and PhD-scientist faculty mentors. Faculty mentors come from the Department of
Anesthesia as well as from multiple clinical and basic science departments across the UCSF campuses. We
focus recruitment efforts on outstanding MD and MD-PhD candidates who are completing or have already
completed their anesthesiology residency or clinical fellowship in an anesthesia subspecialty. We also
occasionally appoint outstanding physician trainees from other clinical disciplines or PhD scientists, provided
they are doing research training with faculty in the Department of Anesthesia and that their research and
career goals are directly aligned with the mission of academic anesthesiology. We request to continue with 4
slots per year. This will allow us to accommodate the research trainee pool derived from the Research
Scholars Track of the Anesthesia Residency, which is a 4-year program (PGY2-PGY5/CA1-CA4) that includes
2 years of protected research time, and to bring in additional individuals through our categorical residency and
clinical fellowships. We will require a 2-year minimum commitment to the T32 training program, but we will
encourage some trainees to do 3 years of training if it is appropriate for their individualized research training
program. Our T32 program prepares trainees to become independent investigators performing research on a
wide range of topics that are relevant to the field of anesthesiology and helps to lay the groundwork for their
development into leaders in academic anesthesiology and research.

Public health relevance
PROJECT NARRATIVE Anesthesiologists play a critical role in the treatment of a wide range of health issues for diverse patient populations in multiple clinical arenas. The breadth of the field affords anesthesiologists the capacity to contribute enormously to basic, translational and clinical research and to push forward discovery, knowledge and care of patients in the operating room, intensive care units, pain medicine clinics, and other perioperative settings. This training grant program will provide the next generation of anesthesiologists and allied scientists with rigorous training in biomedical research so that they can bring more scientific discoveries to patients, and carefully document the safety, efficacy, and importance of the discoveries.